GENETIC BASIS OF FAMILIAL NEUROGENIC DIABETES INSIPIDUS

DNA will be isolated form WBCs of subjects with familiar neurogenic DI and the sequence of arginine vasopressin determined to see if there is a specific base deletion/alteration as the cause of the AVP deficiency in affected individuals in these kindreds.